Common and distinct early environmental influences on cardiometabolic and respiratory health: Mechanisms and methods

Project Summary/Abstract
Obesity and asthma are the two most common chronic conditions in children. Obesity is a risk factor for
asthma as well as for dyspnea not associated with airflow obstruction. Reciprocally, asthma symptoms and
some asthma medications may increase risk of excess weight gain. Because no effective cures exist, and
because both conditions are often established before school age, early life prevention is critical. Yet our ability
to identify the most promising environmental or behavioral targets for prevention has been hampered by the
fact that many exposures may be difficult to measure, often overlap and interact, and rarely occur at a single
point in time. Individuals may vary in their sensitivity to exposures because of genetic or other factors.
Furthermore, obesity and asthma themselves are not static – each may first emerge in early childhood, later
childhood, adolescence, or adulthood; once present they may persist, remit, or worsen; and the two outcomes
may interact. Sophisticated analytic approaches are needed to handle the complex natures of both longitudinal
birth cohort data as well as of the questions themselves.
To this end, we propose this project, which is grounded in our large Boston-area Project Viva pre-birth cohort.
We recruited mothers in early pregnancy, and have followed them and their children at frequent in-person visits
(after delivery and at infancy, early childhood, mid-childhood, and the nearly completed early teen visits) as
well as via annual questionnaires. Building on the outcomes we have already assessed from birth through
early adolescence, we now propose to characterize adiposity and cardiometabolic health measures as well as
lung function and respiratory symptoms into the mid-teen years.
Using state of the art statistical methods, we will address the early life environmental exposures that, singly
and as mixtures, influence the separate and co-evolution of obesity, asthma and related dysfunctions. We will
refine exposure measures, characterize outcome trajectories, and disentangle confounding, mediation and
moderation in associations of exposures with outcomes. Finally, we will use agent based simulation models
that will draw from but also go beyond the results from our own cohort, to identify optimal levers for effective
intervention, incorporating multiple levels of action from physiologogy all the way up to policy. We will
contribute the data, measures, and methods we refine within our cohort to the larger ECHO enterprise, as well
as findings to be followed up in the large synthetic cohort with its diversity representative of children
nationwide.

Public health relevance
Project Narrative Obesity, asthma, and associated cardiometabolic and respiratory dysfunction have major repercussions for quality of life, health care utilization and costs, and longevity. The overall goal of our proposal is to address the question: “What environmental exposures from conception to age 5, singly and as mixtures, influence the separate and co-evolution of obesity, asthma and related dysfunctions?” We will contribute to ECHO exquisite measures of early-life exposures, covariates, and pathways, core child health outcomes through the teen years, and innovative methods, as well as findings to be followed up in the large synthetic cohort with its diversity representative of children nationwide.